Investigation of a thalamic-hippocampal pathway in contextual fear suppression and extinction

Project Summary
Post-traumatic stress disorder (PTSD) is an anxiety disorder that can follow from witnessing or directly experiencing an event
involving injury, threat to life, or death. People with PTSD re-experience the traumatic event through flashbacks or nightmares
and may feel anxious, numb, or hyperaroused. PTSD can last for years and severely impair day-to-day functioning. The condition
exacts an enormous toll on trauma survivors, their families, and society. Moreover, we may be underestimating the individual
and societal costs of PTSD, given growing appreciation that PTSD contributes to other chronic and costly physical health
problems such as cardiovascular disease. Although treatments for PTSD exist, it remains a difficult and stubborn disorder to
treat with many patients resistant to current methods. This issue is in part due to a lack of understanding of the neuronal
mechanisms involved in the retrieval of traumatic memories and how they are suppressed or extinguished in normal subjects.
It has recently come to light that a subregion of the thalamus called the Nucleus Reuniens (NR) plays a key role in the suppression
of fear memories and their extinction – a process in which animals learn that a previously fearful situation is now safe and thus
is no longer feared. Understanding how the NR suppresses and extinguishes fear memories is therefore essential for developing
effective treatments for PTSD, but this is currently unknown. The hippocampus is a central brain region for the formation,
consolidation, and retrieval of contextual fear memories, those that become maladaptive in PTSD patients. NR must therefore
interact with the hippocampus to suppress contextual fear memories and support extinction processes. Anatomically, there is a
direct connection between NR and the CA1 region of the hippocampus, but physiologically is remains unknown how this
pathway interacts with contextual fear memory processing in CA1. To address this, we have developed a new paradigm whereby
contextual fear memories can be induced, later retrieved, and eventually extinguished in head-fixed mice exploring virtual reality
contexts. This allows us to use 2-photon microscopy (as mice are head fixed) to image the activity of NR inputs directly in CA1
during fear memory retrieval and throughout extinction. We can also manipulate the activity of these inputs using optogenetics
and measure the effects on hippocampal population dynamics and single cell activity. It also allows us to image the dendritic
activity of CA1 cells during NR input manipulations. Together, this strategy will uncover how NR interacts with hippocampus
to suppress fear memory retrieval and promote extinction at the synaptic, single cell, population, and circuit level. These finding
will provide new insights that can be used to help develop novel strategies for the treatment of PTSD.

Public health relevance
Project Narrative The annual cost to society of anxiety disorders, such as post-traumatic stress disorder (PTSD) is estimated to be over $42 billion, often due to inadequate treatment. PTSD is characterized by intrusive and debilitating fear responses during memory retrieval that are difficult to treat due to a lack of understanding of the neural mechanisms that underlie fear memory retrieval. The research proposed here will provide detailed mechanistic insight into how brain circuits regulate fear memory retrieval which could reveal novel targets for the treatment of PTSD.